Quantifying medical exposures to radiation in children with congenital heart defects using advanced Monte Carlo methods and patient-inspired anatomical models

PROJECT SUMMARY
Congenital heart defects (CHDs) are abnormalities of the heart and intrathoracic great vessels present from
birth, with varying degrees of health severity; some may necessitate no intervention, while others may require
immediate surgical intervention. Given that CHDs are the most frequent type of birth defect, many children
worldwide will undergo numerous imaging examinations utilizing ionizing radiation, spanning from initial
diagnosis to treatment and long-term follow-up. Considering the latency period for the development of leukemia
from 5 to 7 years, and a minimum of 10 years for solid cancers, there is a tangible risk of developing radiation-
induced malignancies for patients with extended lifespans. Both the National Academies and the United Nations
are currently emphasizing the need to establish low-dose epidemiology cohorts for pediatric patients undergoing
cardiac catheterization procedures, computed tomography scans, and general radiography examinations. This
emphasis arises from the existing paucity of data on the correlation between multi-modality, cumulative, low
radiation doses, and the corresponding cancer risk in children. Currently, there is no accurate platform for
calculating patient-specific organ doses from medical exposures, which hinders our understanding of the link
between radiation exposure and cancer incidence in this vulnerable population. Innovations in artificial
intelligence-based automatic segmentation tools have allowed efficient extraction of patient anatomy from
computed tomography scans to be used in the creation of whole-body phantoms suitable for Monte Carlo
radiation transport simulations. Therefore, I hypothesize that the development of a software system integrated
with the clinical workflow can use available patient imaging examinations to create accurate whole-body mesh
models, which can then be used to calculate organ radiation doses accrued from the diagnosis and treatment of
CHDs using Monte Carlo radiation transport simulations. The proposed project will be achieved by the completion
of four Specific Aims: Aim 1: develop software tools that leverage available patient imaging exams to create
morphometrically matched computational phantoms of the patient suitable for radiation transport simulations.
Aim 2: develop a Monte Carlo software system that integrates with the clinical workflow to compute organ doses
for pediatric patients undergoing cardiac catheterization procedures. Aim 3: use existing Monte Carlo dosimetry
systems that integrate with the clinical workflow to compute organ doses for pediatric patients undergoing CT
and radiography examinations. Aim 4: perform a retrospective study on patients recently treated at UF Health
to compute organ doses for cardiac catheterization procedures, CT, and general radiography examinations.
Completion of these aims will provide an accurate platform that answers the call for more low-dose and radiation
epidemiological research as well as the potential for assisting physicians in patient cancer surveillance.

Public health relevance
PROJECT NARRATIVE A congenital heart defect is the most common type of birth defect and medical care for them can span a child’s entire lifetime. In treating these defects, clinicians often use many imaging modalities involving ionizing radiation, potentially exposing the child to high cumulative radiation doses and increasing their risk of developing radiation- induced malignancies. This study proposes a deployable, clinically integrated software system that will compute organ radiation doses from each imaging procedure a child undergoes in the treatment of a congenital heart defect using patient-inspired anatomic models for both the establishment of low-dose epidemiology cohorts and assisting physicians in cancer surveillance programs.